Complex Systems Approaches to Advance Maternal Health Disparities Research and Prevention: Developing a System Dynamics Simulation Model of Severe Maternal Morbidity among Black Women

PROJECT SUMMARY
Non-Hispanic Black women (NHBW) are twice as likely as NH White women to suffer SMM, which in-
creases risk for maternal mortality. Although the clinical cause of SMM is multifactorial, the disparity is driven
by structural racism. Despite the breadth of knowledge and existing preventive strategies, prolonged SMM dis-
parities suggest that current efforts alone are insufficient to achieve equity. Thus, alternate approaches are
needed to transform understanding of the causes of SMM disparities and to generate breakthroughs in preven-
tion. We argue that SMM disparities are best conceptualized as dynamically complex systems, consisting of
tightly coupled elements that continually evolve over time. Thus, to address SMM disparities among NHBW,
we will apply complex systems approaches – namely, system dynamics (SD) modeling and system dynamics
group model building (SD GMB) – to answer complexity-informed research questions and enable more effica-
cious prevention strategies.
The overall aim of this project is to apply complex systems approaches to generate a holistic under-
standing of the dynamically complex systems underlying SMM outcomes among NHBW, and then
translate this understanding into a novel, evidence-based simulation model to be used for evaluating
the effectiveness of interventions that can curb SMM outcomes among NHBW. Our specific aims are as
follows: 1) to use SD GMB to create a qualitative SD model of the dynamically complex systems that generate
SMM outcomes among NHBW; 2) to translate the qualitative SD model into a quantitative SD simulation
model; 3) to identify, evaluate, and enhance the effectiveness of existing and plausible interventions that can
reduce disparate SMM outcomes among NHBW; and 4) to disseminate the quantitative SD model as a simula-
tion-based dashboard for stakeholders and researchers aiming to reduce SMM outcomes among NHBW.
The successful completion of this project is expected to transform understanding of the development and
perpetuation of SMM disparities by: a) using systems science methods to identify effective solutions to re-
duce racial gaps in health; b) disseminating insights to diverse stakeholders to guide broader community-
level healthcare and social policy decision-making in the presence of dynamic complexity; and c) providing
an initial SD model of maternal health disparities that can spur replication across other contexts. This project
will also impact health disparities research more broadly by: a) demonstrating the potential of convening di-
verse perspectives in maternal health, complex systems science, and participatory research methods in
health disparities research; b) providing transformative evidence of the utility of complex systems approaches
in maternal health disparities research and prevention; and c) generating the first SD model of SMM dispari-
ties that can be expanded or adapted to other contexts (e.g. as a national model), with anticipated and plau-
sible impacts for the broader public and population health fields and related disciplines.

Public health relevance
PROJECT NARRATIVE Driven by structural racism, non-Hispanic Black women are two times as likely as non-Hispanic White women to suffer from severe maternal morbidity, which increases risk for maternal mortality. Using participatory system dynamics modeling methodologies, this project will generate a holistic understanding of the dynamically complex systems that perpetuate severe maternal morbidity disparities among non-Hispanic Black women. This understanding will then be transformed into a system dynamics simulation model that will be developed, tested, analyzed, and disseminated to provide an evidence-based decision-making tool to inform intervention strategies.